Community Engagement Core

ABSTRACT – COMMUNITY ENGAGEMENT CORE
The Community Engagement Core's (CEC) overall goal is to ensure that community member expertise is
incorporated into both the design and dissemination of all research and engagement activities. The CEC will
accomplish this through a data justice framework. Data justice is defined in this proposal as fair procedures for
making people and environmental harms visible through data. The CEC's specific aims include: 1) Improve
researcher and community capacity for data justice; 2) Fill critical data gaps by increasing participation
in community science initiatives; and 3) Enhance the relevancy of NC C-CAPE research to environmental
health advocacy led by Black, Indigenous, and People of Color (BIPOC) communities. To address the
tensions and power dynamics inherent in engaged research, we will produce a data governance charter, create
data justice curricula, convene workshops, and build critical infrastructure to transform existing citizen science
projects into a connected enterprise that fills data gaps in order to better understand and reduce environmental
health disparities. Efforts will transform anglers and boaters likely to volunteer for citizen science into community
scientists using recruitment methods to steer data collection toward gaps that meet the priorities and needs
expressed by BIPOC community leaders in workshops. The CEC will be governed by a Community Advisory
Board consisting of community environmental and health experts from coastal North Carolina and the Internal
Steering Committee consisting of the Center Director, Co-Director, Project 3 Leader, and Dr. Cutts, an
environmental justice researcher, as the CEC Director. A full-time Business Manager will devote effort to both
the Administrative Core and CEC, to align logistics of Center activities, track Center-wide metrics in support of
the program evaluation plan, and accountability to NC C-CAPE partners and stakeholders. Additional hourly
staff will train and educate community specialists living and working in coastal North Carolina. NC C-CAPE will
provide significant insight to guide efforts to implement effective monitoring approaches, inform guideline values
for safe consumption of water and seafood, deliver predictive tools to assess emergent and future toxin exposure
risk, and will leverage community engagement initiatives to fill data gaps to improve oceans and human health.